Adult Relationship Sequelae of Child Abuse and Neglect: Multiple Developmental Cascades

Modified Project Summary/Abstract Section

ABSTRACT: PROJECT 2 Child abuse and neglect (CAN) is a robust risk factor for the development of significant social difficulties in adulthood. However, the predominant use of retrospective measures of broad ill-defined CAN experiences in broader cross-sectional designs that rely on single methods or informants has limited our understanding of the associations among specific dimensions of CAN and characteristics of close relationship experiences in adulthood. Moreover, from a public health perspective, the CAN experiences of individuals are substantially underrepresented in the scientific literature in spite of the disproportionate suffering they experience as victims of CAN with respect to substantial barriers to health care access. Finally, at a substantive level, studies have yet to systematically delineate the mediating processes and moderating conditions that account for the multiple developmental cascades linking CAN with close relationship sequelae in adulthood. To address these substantial gaps in scientific knowledge, the present application is designed to provide the first test of an integrative process model of the relational vestiges of CAN in adulthood. Specific aims are centered on examining: (1) the selectivity and breadth of prospective associations among CAN dimensions and multiple domains of intimate partner and parent-child relationship qualities; (2) the psychological mechanisms that mediate the adult relational sequelae of CAN; and (3) the multi-level moderating conditions that potentiate or disrupt the mediating cascades linking CAN with close relationship experiences in adulthood. Given the relative lack of research on participants from varied demographic backgrounds, the proposed application is specifically designed to advance an understanding of the sequelae of CAN. Building on the solid base of an integrative conceptual framework and promising preliminary findings, this application will test these aims by following up a sample of 427 28- to 32-year-old adult participants who experienced substantially elevated CAN and participated in data collection ding early adolescence (Wave 1: 10-12 years old) and emerging adulthood (Wave 2: 18-20 years old). To overcome the existing methodological limitations in the literature, we capitalize on a multi-method (e.g., observations, surveys, semi-structured interviews, structured interviews, q-sorts), multi-informant (e.g., trained coders, counselors, primary caregivers, friends, peers), and multi-level (i.e., ecological, family, interpersonal, intrapersonal, neurocognitive, neurobiological) measurement battery across three prospective measurement occasions encompassing more than two decades. By identifying the mechanisms and conditions underlying links between CAN and adult relational sequelae, this application will provide critical information for clinical and policy initiatives designed to maximize the welfare of children and families.